Gestational hypertension and preeclampsia blood pressure (BP) Treatment goals <140/90 vs. <160/110 mmHg: The GOALPOST Trial

ABSTRACT
Hypertensive disorders of pregnancy (HDP) affect up to 1 in 8 pregnancies and lead to significant short and
long- term morbidity and mortality for mothers and neonates. HDPs are classified as non-severe and severe. In
non-severe forms of HDP, specifically gestational hypertension or preeclampsia without severe features,
pregnant individuals have elevated systolic blood pressure (BP) between 140 – 159 mmHg and/or elevated
diastolic BP 90 – 109 mmHg without evidence of end-organ dysfunction. In contrast, severe HDP, including
preeclampsia with severe features and eclampsia, is characterized by severe hypertension defined as BP
≥160/110 mmHg or evidence of end-organ damage such as liver or kidney dysfunction or seizures. Although
delivery minimizes risks to the mother, depending on the gestational age, delivery may lead to increased risks
for the neonate, particularly adverse outcomes associated with prematurity. Five percent or more of all
pregnancies are affected by non-severe HDP at <370 weeks. The standard of care is to expectantly manage
patients with non-severe HDP with close observation and serial surveillance until 370 weeks gestation or when
severe disease develops, whichever occurs first, at which time delivery is indicated. Unfortunately, non-severe
HDP progresses to severe HDP in 30 - 50% of cases <370 weeks gestation. As such, it is critical to identify
interventions to safely reduce the progression from non-severe to severe HDP. A recent trial in pregnant women
with chronic hypertension demonstrated that treatment of BP to a goal of <140/90 decreases the risk of
preeclampsia and improves outcomes for mother and baby. Based on this, clinical guidelines were changed and
now recommend a BP goal <140/90 for all pregnant individuals with chronic hypertension. However, no definitive
trial has been performed demonstrating that BP goals <140/90 in non-severe HDP are beneficial and safe,
leaving the clinical question: Does starting oral antihypertensive medication when a patient develops a non-
severe HDP prolong gestation and benefit the mother and infant without increasing maternal or fetal risks?
Therefore, we propose The GOALPOST Trial, a phase III, open-label randomized control trial (N=4,120) of
antihypertensive treatment in pregnant individuals with non-severe HDP conducted through the NICHD Maternal-
Fetal Medicine Units Network. Participants will be randomized 1:1 to 1) intervention – oral antihypertensive
therapy to targeted BP goals <140/90 mmHg or 2) usual care – no antihypertensive therapy unless BP ≥160/110
mmHg. We will evaluate whether the intervention reduces adverse pregnancy (Primary Aim) and neonatal
outcomes (Secondary Aim). A comprehensive safety plan will ensure close clinical monitoring of mother and
fetus to enhance safety. The GOALPOST Trial has the potential to change management guidelines for the
treatment of non-severe hypertensive disorders of pregnancy in the US and worldwide and to improve outcomes
for countless women and children.

Public health relevance
PROJECT NARRATIVE Hypertensive disorders of pregnancy (HDP) are a group of conditions characterized by new high blood pressure in pregnancy that affect up to 1 in 8 pregnancies. Up to half of women with non-severe HDP develop severe HDP that can cause organ damage in the mother and / or early birth and morbidity of the baby; therefore, interventions that prevent the progression to severe disease are urgently needed. We propose GOALPOST, a clinical trial that will test whether lowering the blood pressure to <140/90 in women with non-severe HDP before 36 weeks of pregnancy will improve outcomes for mothers and babies.